Building Interdisciplinary Research Careers in Women's Health (K12) - Administrative Supplement

7. Project Summary/Abstract
Duke University and North Carolina Central University (NCCU), a historically Black institution, are applying for
additional support for Dr. Tarannum Jaleel, appointed Sept. 2022 and Dr. Binita Chakraborty (postdoc),
appointed Sept. 2023. The Duke/NCCU BIRCWH is a strong, vibrant program that has the leadership and
institutional commitment required for continued success. Our partnership, now in its 24th year, provides the
foundation for a program that encompasses interdisciplinary research, structured mentoring, and individualized
career development for junior faculty, with three major goals: (1) Develop highly skilled, innovative researchers
who use interdisciplinary approaches to investigate women’s health and sex/gender influences across the
lifespan; (2) Foster diversity in women’s health research and advance health disparities research affecting
women’s health by identifying and recruiting scholars from diverse backgrounds and (3) Enable and equip
BIRCWH scholars to lead interdisciplinary teams of scientists, and to become the mentors and leaders of the
future. Drawing on the breadth of expertise at our two universities, we have the capacity to advance the career
development of scholars interested in basic, clinical, or health services research across a broad range of fields.
Our scholars learn to integrate approaches to focus on women’s health and sex/gender differences in human
disease. Scholars’ interdisciplinary mentoring teams include a mentor from our core group of nationally known
senior investigators from Duke and NCCU, with others added to maximize interdisciplinary expertise and
collaborations. Scholars perform intense, hands-on research; course work; and training in grant writing, health
disparities, team science, SABV and RCR. Scholar progress is monitored by the Leadership Team and the
Internal Advisory Committee (IAC). The program is assessed and advised by the IAC and an External Advisory
Committee. External evaluations of our program and scholars are performed by an independent evaluator in
the Duke Social Science Research Institute. The Duke/NCCU BIRCWH program is achieving its goal to
increase the size and influence of a diverse pool of highly trained women’s health researchers who are poised
to address the nation’s biomedical, behavioral, and clinical needs.
We request this administrative supplement to support these two scholars for one additional appointment period
each. This will enable them to complete their BIRCWH project-specific aims, publish their findings in peer-
reviewed journals, and apply for additional independent funding.

Public health relevance
Project Narrative Duke University, a major research university, and North Carolina Central University, a historic black university, both in Durham, NC partner for this career development program in women’s health research. Selected junior faculty members and one postdoctoral trainee from these two institutions receive formal mentoring and training to conduct interdisciplinary research relevant to women’s health across the lifespan emphasizing health disparities and the effects that sex and gender have on health. These well- trained scientists will be the future champions for improving women’s health nationwide and globally.